Vector Flow Velocity Imaging of Human Placenta using Angle-resolved Ultrasound and Deep Learning

This proposal describes a five-year research and career development program to prepare Dr. You Li for a career
as an independent investigator. The program will build upon Dr. Li’s multidisciplinary background as a biomedical
engineer, trained in medical ultrasound imaging, by providing expertise in obstetrics, the application of machine
learning in medical imaging, and translational research. The PI will be mentored at Stanford University by Drs.
Jeremy Dahl (primary mentor, medical ultrasound), Virginia Winn (co-mentor, obstetrics and gynecology), and
Matthew Lungren (co-mentor, radiology and artificial intelligence). Human placenta plays a vital role in human
development, and its abnormalities may cause significant consequences to both the mother and the fetus.
Preeclampsia, in particular, is a common disorder that affects approximately 1 in 33 pregnancies in the United
States and accounts for 18% of pregnancy-associated maternal death. Many placental abnormalities, including
preeclampsia, are related to the hemodynamics and growth of vessels in placenta. Despite the severe
consequences of placental abnormalities, our understanding in placenta and placental abnormalities is lacking.
One primary reason for the gap of knowledge is the inability to observe the hemodynamics of placenta in vivo.
Currently, B-mode and Doppler ultrasound are the primary imaging modalities in imaging the placenta and its
vasculature. However, significant limitations exist in the ability of Doppler ultrasound to visualize and measure
detailed flow velocities in placental vasculature. It has low sensitivity to small vessels in the placenta, including
spiral arteries and chorionic villi, and can only measure flow velocity along the ultrasound beam direction,
requiring tedious manual angle correction for flow along any of the visible vessels if quantitative information is
desired. These limitations make conventional Doppler ultrasound poorly suited for imaging the hemodynamics
of the complex vasculature of human placenta. To provide full and detailed characterization of placental
hemodynamics, we propose to develop a vector flow velocity imaging technique using deep neural network
models and multiple angle plane wave ultrasound transmits. This technique will be able to quantitatively image
both the flow velocity magnitudes and flow directions of millimeter-diameter vessels in human placenta over a
large field of view. Aim 1 and 2 will be focused on the technical development of the technique to provide a semi-
real-time vector flow imaging system based on a research ultrasound scanner, paving way for Aim 3, which will
be focused on validating the clinical value of the technique on a pilot clinical study to image the hemodynamics
in spiral arteries and chorionic villi of pregnant women. Successful completion of the project will provide a novel
technique for the scientific and early clinical assessment of placental hemodynamics, development, and
abnormalities including the development of the villous tree structure, placenta accreta, preeclampsia, and
placental insufficiency. During the project, the PI will receive training in machine learning, obstetrics, translational
research, and career development skills, which will transition the PI into an independent faculty.

Public health relevance
Our understanding in human placenta and its abnormalities is limited, because we do not have a medical imaging device to non-invasively observe the blood flow in the small vessels of human placenta in vivo. To fill this gap, we propose to build a semi-real-time ultrasound vector flow velocity imaging system using deep learning models to provide detailed and quantitative imaging of the flow velocity magnitudes and flow directions in human placenta. The successful completion of the project will provide a novel ultrasound imaging technology for the scientific investigation and early clinical assessment of placental development and abnormalities.